Circuitry mechanisms regulating adult hippocampal neurogenesis

DESCRIPTION (provided by applicant): One striking form of plasticity in the adult brain is the ongoing process of neurogenesis in discrete brain regions of almost all mammals examined to date, including humans. In the adult hippocampus, new neurons arising from resident neural stem cells play important roles in many adaptive behaviors, including learning, memory, homeostatic stress responses and mood regulation. Accumulating evidence also suggests that adult neurogenesis is involved or altered in many pathological conditions, such as epilepsy, developmental psychiatric disorders and degenerative neurological diseases. Therefore, understanding the basic mechanisms of adult neurogenesis may provide clues regarding the etiology and pathology of these mental disorders, and potential novel therapies. While the field has made tremendous progress during past decades, there are major gaps in our understanding of adult neurogenesis that must be addressed to harness the endogenous plasticity and regenerative capacity of the adult brain for functional enhancement or repair after injury or diseases. One fundamental question in stem cell biology is whether and how niche signals calibrate the number of functional progeny based on local tissue demands. As adult hippocampal neurogenesis occurs within a dynamic neuronal network, local circuit activity could serve as an effective readout of current tissue demands and provide a signal to fine tune the neurogenic process. Our central hypothesis is that the neurotransmitter GABA is a dynamic niche factor that couples activation of specific neuronal circuitry to regulation of distinct stepsof adult hippocampal neurogenesis. Previous studies have established a critical role for depolarizing GABA signaling in regulating development of post-mitotic newborn neurons during adult neurogenesis. However, whether GABA also regulates neural stem cells and proliferative neural progeny is largely unknown and there is little data on the function of inhibitory GABA signaling during adult neurogenesis. Aided by new technologies for clonal analysis of individual quiescent neural stem cells and optogenetic manipulation of specific interneuron subtypes, we will investigate the niche source of GABA and the role of local interneuron circuitry in regulating three critical steps of adult hippocampal neurogenesis in vivo, including individual stem cell activation, survival of proliferating progeny, and integration of GABAergic and glutamatergic signaling as newborn neurons mature. Our proposed studies will address fundamental questions in adult neural stem cell biology and neurogenesis. Basic principles learned from these studies may be generalizable to the fields of stem cell and developmental biology, neural plasticity and regenerative medicine.

Public health relevance
This project aims to address outstanding questions regarding the role of neural activity in regulating adult hippocampal neurogenesis. Findings from these studies may have important implications for the field of stem cell biology and the development of novel therapeutic strategies to treat brain injury and neurodegenerative disease using endogenous or transplanted neural stem cells.